PDX Core

PDX CORE PROJECT SUMMARY
The goals of the PDTC PDX Core are to establish and maintain PDX lines for the purpose of conducting animal
preclinical trials using experimental and standard-of-care therapeutics; to promote quality control, reproducibility,
and collaboration by developing and maintaining shared Standard Operating Procedures (SOPs) for PDX
development, maintenance, experimentation, and pathogen testing; to provide infrastructure to manage large PDX
collections and to generate, store, and manage PDX-based experimental data generated by the projects; to
facilitate exchange of PDX models between the PDXNet program; and to facilitate transfer of experimental data
to the PDTC Bioinformatics Core and the PDTC PDXNet Data Commons and Coordinating Center to relate
treatment responses to the molecular characteristics of individual patients’ tumors. Our PDTC PDX Core current
comprises 262 breast PDX lines available for projects within our PDTC Center and across the PDXNet program.